Bone Quality Assessment During Breast Cancer Treatment via Wrist Tomosynthesis in the Mammography Setting

ABSTRACT/PROJECT SUMMARY
Breast cancer (BC) is the most common cancer in the world. A great majority of these cancers are the type called
hormone receptor positive, which are treated with medicine that interferes with estrogen (called aromatase
inhibitors, or AI). As a result, substantial bone loss occurs putting these patients at risk of fracture during or after
therapy. Given that over 90% of breast cancer patients survive 5 years or longer after therapy, such extreme
weakening of bones represents a big problem for a large group of people. This weakening of bones is due to a
complex pattern of bone loss, involving microscopic structure in different parts of the bone. These patterns of
bone loss are also different between people who are young and not yet in menopause compared to those who are
postmenopausal. The standard tool for examining bone health (“DXA scan”) is not sufficient to capture such
minute details of bone. The devices that are able to image these details are not available everywhere, and they
are not in routine use. Additional to this, making appointments for secondary concerns can be overwhelming
and create extra anxiety for cancer patients. For these reasons, breast cancer patients who are at risk of suffering
a fracture down the road may not be identified and may not be helped.
The main idea for this project is to monitor breast cancer patients’ bone quality using the same equipment used
for their mammography and at the same time they receive mammographic follow up. This is technically novel,
because assessing bone quality with the device called tomosynthesis, which is typically used for imaging and
measuring breast density, is a unique use of these devices. Therefore, the main goal of this project is to evaluate
how bone quality metrics measurable from digital tomosynthesis images of the wrist (DWT) change over time in
postmenopausal (Aim 1) and premenopausal (Aim 2) BC patients receiving AI therapy, and how well these
metrics predict computationally derived bone strength and patient fracture status (Aim 3) compared to standard
DXA measures, by performing a set of longitudinal and cross-sectional studies. The proposed project is expected
to provide a complete picture about the utility of the DWT approach in BC patients treated with AIs.
DWT is expected to provide bone density measures similar to DXA. In this case, DWT could take place of DXA
in the mammography setting. Because the patients can receive it during their routine mammographic follow-up,
this would eliminate the unnecessary anxiety from scheduling additional DXA tests and ensure that bone exams
are not neglected. It is further expected that DWT derived microstructure and biomechanical measures, which
are accurate measures of bone mechanical integrity, will be sensitive indicators of bone response to therapy. In
this case, DWT would not only offer a system convenient for the patient and efficient for the health care system,
but it would also offer a more accurate assessment of bone quality and fracture risk. The results of this study will
inform next steps about how to proceed with translating DWT to clinical practice.

Public health relevance
NARRATIVE The knowledge gained from this research may substantially change the clinical approach for monitoring bone health and predicting risk of fracture in breast cancer patients without burdening them with additional imaging appointments. The proposed research aims at establishing a new bone imaging technique with improved accuracy over the current diagnostic standard that can be implemented alongside followup mammography, thereby improving delivery and accuracy of bone health screening and fracture risk assessment. These aims are relevant to NIH’s overall mission, specifically: to the 2020-2024 long range priority areas of NIAMS pertaining to the development or adaptation of non-invasive methods to assess bone quality and determining bone effects of drugs prescribed for diseases of other tissues and systems, which may have an impact on bone quality or fracture risk; to the mission of NCI that pertains to treatment of the symptoms and complications of cancer, including the late effects of cancer and its treatment on the growing population of cancer survivors; and to the mission of NIBIB that pertains to supporting research of new biomedical technologies for early disease detection and improvement of human health.